Task B26: Drug Synthesis Activities for SARS-CoV-2

This task provides for lead identification, development, chemistry and synthesis services under the NIAID Preclinical Services for the Development of Interventional Agents Program.